Optimizing Medications and Lung Health in People with HIV through Pharmacist-led Proactive E-Consults (OPTIMIZE Lung-HIV)

PROJECT SUMMARY/ABSTRACT
Despite effective antiretroviral therapy (ART) for people with HIV (PWH), community acquired pneumonia
remains a common cause of hospitalization, respiratory failure, extrapulmonary complications, and mortality.
Pneumonia continues to be substantially more common among PWH compared to people without HIV, and risk
increases with age and comorbidity. Modifiable risk factors for pneumonia in PWH include active smoking,
inadequate vaccinations, and commonly used potentially inappropriate medications such as inhaled
corticosteroids (ICS) and proton-pump inhibitors (PPIs). Our overarching objective is to improve guideline-
concordant care and decrease population risk of pneumonia in PWH. We will test whether a proactive
pharmacist-driven E-consult intervention increases uptake of appropriate smoking cessation pharmacotherapy,
vaccinations and deprescribing of inappropriate ICS and PPIs for PWH compared to usual care. We leverage a
successful pulmonologist-driven proactive E-consult intervention that improved quality of care for chronic
obstructive pulmonary disease in PWH in the Veterans Health Administration (VHA), and adapt our
intervention by partnering with pharmacists. As pharmacists are integrated into primary and specialty care in
VHA, this model can extend the national reach of our intervention and may be more realistic, cost-effective,
and scalable than pulmonologist delivered E-consults. We will conduct a multicenter, patient-level randomized
controlled, hybrid Type 1 effectiveness-implementation trial and achieve the following specific aims (SA): 1.
Test whether a pharmacist-led proactive E-consult intervention for HIV providers improves evidence-based
pulmonary pharmacotherapy in PWH; 2. Identify key factors influencing the process of adoption,
implementation, maintenance and scalability of pharmacist-led proactive E-consults. We will determine clinical
effectiveness by the proportion of medication recommendations enacted within 3 months (primary outcome)
and at 12 months for maintenance (secondary outcome) comparing results between E-consult and usual care.
We will conduct mixed methods assessments to evaluate barriers and facilitators to implementation and for
effective adoption and maintenance of a proactive E-consult program, guided by the Consolidated Framework
for Implementation Research (CFIR). We will use the RE-AIM (Reach, Effectiveness, Adoption, Implementation
and Maintenance) framework to evaluate program outcomes and assess adoption, appropriateness and
acceptability to patients and providers as well as implementation costs to inform wider dissemination, and
understanding of what factors may be critical for the success, maintenance and scalability of the program. This
project will yield critical findings on effectiveness and sustainability of pharmacist-led proactive E-consults to
improve delivery of pharmacotherapy. Our initial focus is on improving guideline-concordant pharmacotherapy
and decreasing excess risk for pneumonia in PWH. If successful, our approach could be expanded to include
pharmacist led interventions focused on other medications that are commonly under or over-prescribed.

Public health relevance
PROJECT NARRATIVE Despite good HIV treatment, pneumonia is still a leading cause of death and disability in people with HIV (PWH). Our project will use pharmacists to review charts and medications of PWH and make medication recommendations that can reduce pneumonia risk. This project will determine if and how pharmacists can improve the health of PWH.